Epitope-driven deimmunization of Factor VIII

DESCRIPTION (provided by applicant): Hemophilia A patients are prone to develop inhibitory immune responses to the very therapy they require: Factor VIII protein replacement. Up to 30% of all hemophiliacs and greater than 50% of severe hemophiliacs produce antibodies (inhibitors) in response to treatment. Immunogenicity to Factor VIII (FVIII) is its most significant complication: immunogenicity not only reduces or eliminates the therapeutic efficacy, but also requires that FVIII be delivered by invasive routes since less invasive routes are known to further increase the immunogenicity of therapeutic proteins. To address this problem, it is necessary to develop a less immunogenic FVIII that will provide hemophiliacs with the benefits of prophylactic Factor VIII therapy without the interference of neutralizing antibodies. Neutralizing antibody formation, the root cause of FVIII therapy failure, is a process dependent on antigen presenting cell signaling to helper T cells. We thus propose to develop a de- immunized version of FVIII by T-cell epitope modification. FVIII contains highly immunogenic T- cell epitopes that are excellent targets for mutation in order to prevent T cell-dependent antibody formation. The aims of this Phase I SBIR are to (1) identify and select the key immunodominant T-cell epitopes in FVIII that are responsible for its immunogenicity, (2) strategically modify those epitopes using point amino acid changes as guided by EpiVax'validated immunoinformatics tools and techniques and (3) to demonstrate that reengineered individual FVIII domains have reduced immunogenicity in a mouse model of hemophilia. A series of FVIII domain variants bearing single epitope modifications will be produced and their immunogenicity will be evaluated. The focus of a Phase II SBIR will be studies of FVIII constructs bearing multiple epitope modifications (combinations of the modifications identified during Phase I). These research and development programs will lead to the development of a commercially available and fully functional Factor VIII protein that has significantly reduced immunogenicity as confirmed in HLA transgenic mice and Factor VIII deficient mice. Epitope-driven deimmunization of factor VIII 12,000 Americans have the blood clotting disorder Hemophilia A, and as such are susceptible to a host of complications from chronic bleeding of the joints to life threatening blood loss due to traumatic injury. This proposal describes a plan to produce an improved clotting protein (Factor VIII) that could be used to treat hemophiliacs since the current treatment is often rejected by the body. The proposed reengineered protein will be evaluated in a mice that have a hemophilia as well as in mice that have a human- like immune system.